Policy Implementation Research of Earmarked Taxes for Mental Health Services

PROJECT SUMMARY
Insufficient funding is frequently identified as a barrier to maximizing the reach of evidence-based practices
(EBPs). As such, increasing access to new funding is recognized as an implementation strategy. Earmarked
taxes—defined as taxes for which revenue can only be spent on specific activities—are an increasingly popular
financing strategy that could improve the reach of EBPs. Approximately 51 million people in the U.S. (16% of
the population) currently resides in a jurisdiction that has implemented an earmarked tax for MH services.
These taxes are likely to become increasingly common amidst growing public demand for enhancement of MH
service systems. However, little is known about how the design and rollout of earmarked taxes might be
optimized to ensure that revenue is allocated for services that are evidence-based. Little empirical guidance
exists to inform the design of earmarked taxes or selection of implementation strategies to ensure that they
improve the reach of EBPs. The dearth of evidence about tax implementation reflects the fact that policy is
understudied in D&I research. The project's specific aims are to: 1) Identify all jurisdictions in the U.S. that
have implemented earmarked taxes for mental health services and catalogue information about tax design; 2)
Characterize county mental health agency leaders' experiences implementing earmarked taxes, understand
the determinants of decisions about tax-funded services using the EPIS framework, and assess the
acceptability and feasibility of different types of implementation strategies; and 3) Develop a conceptual policy
implementation framework to improve earmarked tax design, inform the selection of implementation strategies
to increase the taxes' reach of EBPs, and disseminate the framework to relevant policy audiences. These aims
will be achieved by a legal mapping study, survey of 300 county mental health agency leaders in approximately
90 counties that have implemented earmarked mental health taxes, 50 semi-structured interviews in four
purposively selected counties, and integration and quantitative and qualitative data through a systematic
framework development process. The project is innovative because it studies an unexplored D&I topic and is
significant and will have impact because it will provide an empirical basis to select implementation strategies
for earmarked taxes to enhance EBP reach. This study will set the stage for a hybrid Type 2 R01 that will apply
the developed policy implementation framework to test the effects of these strategies on implementation and
clinical outcomes. The project team consists of early/mid-career D&I scientists with expertise in mental health
policy D&I research and legal mapping (Purtle, PI) and D&I in publicly-funded mental health services
(Stadnick, Co-I) and senior investigators involved with tax implementation in California (Aarons) and
Washington (Bruns and Walker).

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it will generate knowledge about how to enhance the ability of earmarked taxes for mental health to increase the reach of evidence-based practices that improve population mental health. More broadly, the project will generate knowledge about how public policies and funding affect decisions about the decisions of evidence-based treatments.